Optimizing PrEP implementation and effectiveness among women at high risk for HIV acquisition in South Africa

Project Summary/Abstract
This application is to provide mentorship and career development to a promising URM as part of a diversity
supplement to grant R01MH121161. The parent award seeks to understand ongoing implementation of PrEP
service delivery across two large CDC/PEPFAR funded awards to TB HIV Care in South Africa, which serve
the HIV prevention female sex workers and adolescent girls and young women nationally. The parent award
further aims to optimize PrEP implementation strategies to enhance PrEP uptake and persistence among
women, through short duration cluster randomized trials which test modifications and additions to ongoing
program implementation. The proposed application, will build upon the existing study objectives and expand
the scope by studying the adaptation of strategies over time, as well as the impact of these adaptations on the
fidelity of implementation. These adjustments are beyond the scope of the currently funded study which
assessed the impact of the introduction of implementation strategies on PrEP uptake and persistence, and is
studying the relationship between new/tweaked strategies on PrEP performance outcomes. Assessing
adaptation of strategies over time is new, and will help to elicit new insights into fidelity of implementation,
including fidelity consistent and fidelity inconsistent adaptations, which will provide further insights into program
performance over time, as well as durability of implementation and impact of implementation strategies.
Training activities will focus on expanding skillsets of the candidate, an underrepresented minority from a
disadvantaged background, in implementation science, qualitative research methods and causal inference,
preparing the candidate for a future research career. The mentoring team has several collective years of
mentorship experience, including in implementation science, quantitative and qualitative research methods,
PrEP programming, clinical research and practice and infectious disease epidemiology.

Public health relevance
Narrative/Relevance This diversity supplement is to support the career development of Wilson Gomez, a promising early career researcher. The supplement activities will contribute to and expand on the scope of activities for parent grant R01MH121161, which focuses on optimizing PrEP implementation for young women at high risk of HIV acquisition in South Africa. The current application will focus on adaptation of implementation strategies over time, and the impact of these adaptation on fidelity consistent implementation; this work aligns well with the goals of the parent R01, but if beyond the scope of currently funded activities.